Multidisciplinary Investigations in Visual Science

PROJECT SUMMARY The goal of this NEI Center Core application is to enhance the research activities of NEI-funded investigators at The University of Iowa. This will be achieved by providing a complement of Service Cores. Each Core will offer a set of services - performed by skilled technical staff and supervised by experienced NEI-funded faculty members, employing standardized, automated procedures when possible. The combination of centralization (allowing specialization and concomitant increases in efficiency) and the breadth of services available from the various Core Modules are expected to provide utility and increased productivity to all vision researchers at The University of Iowa. This supports three primary foci: 1) histological and ultrastructural studies, 2) detailed phenotyping in the mouse, and 3) computational analysis of large-scale image and genotype data. These capabilities all require specialized equipment and highly trained staff that would be inefficient to duplicate in every lab employing these techniques.

Public health relevance
PROJECT NARRATIVE The visual sciences research cores centralize common research techniques so work is performed in an efficient and standardized way without the need to duplicate equipment and specialized staff. The services available from the cores provide utility and increased productivity to all vision research at The University of Iowa.